From Symbiosis to Dysbiosis and Back: The Impact of Pro-Inflammation and Pro-Resolution

Periodontitis is initiated by oral bacteria, but quickly transits to an inflammatory immune disease with loss of host-
bacterial homeostasis. Homeostasis, the symbiotic balance between host tissues and the resident periodontal
microbiome is disrupted by a dysregulated immune response. From symbiosis to dysbiosis, early innate immune
components are robustly linked. At the host-microbial interface, we have ample evidence that microbes trigger
the immune response but lack knowledge of how the immune response regulates the composition and functional
activity of the microbiome. Specialized Pro-resolving Mediators (SPMs) are a family of eicosanoid lipid mediators
that bind to specific cell receptors to coordinate the return of an inflammatory lesion to homeostasis. Among the
many SPMs, E-series resolvins are naturally occurring metabolites of transformation circuits of the omega-3 fatty
acid, eicosapentaenoic acid (EPA), that actively induce resolution of inflammation. Activation of the Resolvin E1
(RvE1) receptor (ERV1) in gain-of-function studies with the ERV1 transgenic mouse (ERV1tg), show profound
resistance to periodontitis. The use of resolvins to control inflammation allows us to test our central hypothesis
that early immune activation directly contributes to the development of periodontal dysbiosis, which can be re-
versed/prevented by activating Resolivin-E1 mediated resolution of inflammation pathways. To test this hypoth-
esis, we break our investigations into two levels. First, in a murine model, we will characterize the oral microbi-
ome’s functional and spatial organizational changes as symbiosis transits to dysbiosis. Second, we will use an
in vitro system to unravel the mechanisms that determine how RvE1 and its receptor (ERV1) influence the dy-
namics of dysbiosis and inflammatory/immune responses in periodontitis. The candidate is a DDS/PhD perio-
dontist who is committed to an academic career dedicated to improving periodontal and oral health. The men-
tored phase of the proposal will be carried out with Dr. Thomas Van Dyke (Primary mentor) and Dr. Xuesong He
(Co-mentor) at the Forsyth Institute. The goal of the K99 phase is to provide additional training, mentoring, and
experience in three important areas 1) advanced bioinformatics training for microbiome data; 2) study design
and biostatistics training; and 3) career development. A strong Scientific Advisory Committee from the Forsyth
Institute, Harvard Medical School, and the University of Washington has been established with diverse expertise
in immunology, microbiology, bioinformatics, and statistics to help guide the candidate providing a training plan
that complements and expands her scientific background with mentors whose expertise spans the broad scope
of the scientific problem. The scientific component and training outlined in this proposal provide a pathway for
the candidate to transit to an independent research career in a tenure track faculty position independent of the
research programs of the mentors. Successful completion of this project will lead to better understanding of
host-microbiome interactions and how to gain control of the inflammation/dysbiosis cycle in periodontitis to ame-
liorate disease.
1

Public health relevance
Project Narrative: A deeper understanding of mechanisms underlying periodontitis, a condition that affects 42% of the US adult population, will enhance management of a significant public health problem. This proposal is structured to test the hypothesis that periodontitis is the result of loss of host/microbiome homeostasis induced by excess inflammation that has direct actions on the composition and function of periodontal bacteria. By investigating host-microbiome interactions, we will identify specific targets and potential molecules for treating periodontal disease and breaking the inflammatory disease cycle. 1